BLR&D Research Career Development Transition Award Application

The applicant, Aliza Wingo, M.D., M.Sc., is a board-certified psychiatrist and principal investigator at the
Atlanta VA Medical Center. The first focus of Dr. Wingo’s research is to identify the genetic and molecular
contributors to psychological resilience, PTSD, and depression, respectively. She is keenly aware of the
complex relationships among these three facets of mental condition and also works to identify common and
distinct mechanisms among them. The second focus of Dr. Wingo’s work is to identify how resilience, PTSD,
and depression share common genetic and molecular basis with Alzheimer’s disease dementia. Through
studying psychological constructs, she aims to identify novel pathways for enhancing resilience, treating
PTSD/depression, and identifying novel causes of Alzheimer’s dementia that could be leveraged for new
therapies. This work is currently supported by a Merit Review award from the VA, an R01 from the NIA/NIH,
and a U01 from the NIMH/NIH.
With regard to resilience, Dr. Wingo has shown that a genetic variant on chromosome 1 (rs322931) and
brain expression level of miR-181 contribute to resilience (Wingo et al, Molecular Psychiatry, 2016). Resilience
here is conceptualized as having high levels of positive emotions and/or sense of life purpose and meaning
after adverse or traumatic life experiences. In her current funded Merit Review, Dr. Wingo examines brain
microRNA profile to identify a microRNA signature of resilience. Next, she will use systems biology approach to
identify brain transcriptomic drivers of resilience using brain transcriptome. Finally, she will examine the
mRNAs and proteins that are downstream targets of the resilience-associated microRNAs with the overall goal
of identifying novel genes regulating resilience.
Regarding PTSD and depression, Dr. Wingo has shown that DICER1 and microRNA regulation
pathway contributes to PTSD and depression (Wingo et al, Nature Communications, 2016). In this CDTA, Dr.
Wingo proposes to harness deep human brain proteomes quantified by mass spectrometry from post-mortem
brain tissues as a reference to impute brain protein expression level in Veterans who have genotyping. The
imputed protein expression profile is then used for a proteome-wide association study of PTSD and
depression, respectively, to identify proteins in the brain that predispose to PTSD or depression. In addition,
epidemiological studies have observed that offspring of pregnant women suffering from PTSD or depression
have higher risk for developing psychological or behavioral issues later in life. To investigate the mechanisms
behind this intergenerational association, Dr. Wingo has been funded by a U01 to examine offspring’s blood-
based transcriptome and global microRNA profile. These findings are highly relevant to female Veterans who
suffer higher risk for PTSD and depression.
Regarding dementia, Dr. Wingo has shown that hundreds of proteins in human brain are altered with
cognitive decline in advanced age (Wingo et al, Nature Communications, 2019). Since large epidemiological
studies have observed that depression, especially late-life depression, increases the risk for dementia, Dr.
Wingo is funded by an R01 to elucidate molecular mechanisms underlying detrimental effects of depression
and protective effects of life purpose on Alzheimer’s dementia risk using multi-omics data from post-mortem
brain tissues.
Through studying the genetic and molecular mechanisms underlying the conditions that
disproportionally affect our Veterans – PTSD, depression, and Alzheimer’s dementia, Dr. Wingo hopes to
contribute to advancing our understanding of their etiologies to develop novel and effective interventions. As a
long-term goal, Dr. Wingo aspires to carry out novel and innovative research questions to make transformative
impact on the health and resilience of our Veterans.

Public health relevance
The research program of Aliza Wingo, MD, MSc, addresses the VA priority research areas including PTSD, Alzheimer’s dementia, women veteran’s health, and genomic medicine. Particularly, Dr. Wingo studies the genetic and molecular mechanisms that underlie the conditions that disproportionally affect Veterans - PTSD, depression, Alzheimer’s dementia, and detrimental effects of maternal PTSD on offspring outcomes. Another important aspect of Dr. Wingo’s research effort is to elucidate the genetic and molecular basis of resilience, conceptualized as adaptive coping in the context of stress, adversity, or trauma. In this novel and cutting-edge CDTA application, Dr. Wingo proposes to identify proteins in the human brain that i) predispose one to PTSD or depression, and ii) contribute to resilience after adverse or traumatic life experiences. From these studies, Dr. Wingo hopes to contribute to a better understanding of the neurobiology of PTSD, depression, and Alzheimer’s dementia in order to find more effective interventions and enhance resilience among Veterans.